The Role of Proton-Activated Chloride Channel 1 (PACC1) in Bacterial Pneumonia and Sepsis

Project Summary/Abstract
Bacterial diseases constitute a major global burden, primarily due to respiratory, peritoneal, and blood infections.
Our lab and others have demonstrated that investigating host-derived innate immune responses may elucidate
pathways important for combating bacterial threats. Myeloid cells, such as tissue-resident alveolar macrophages,
serve as an essential first line of defense. Because phagocytosis of bacteria and subsequent microbial lysis in
the acidified phagolysosome are an integral part of their response, targets that regulate the phagolysosome are
of major physiological significance and could possibly lead to points of clinical intervention during infection.
Interestingly, chloride anion (Cl-) governs a range of biological functions, including intracellular vesicular
acidification and cell signaling. Over the past four years, a new Cl- channel, proton-activated chloride channel 1
(PACC1), has been discovered and structurally characterized. However, the main biological role of PACC1
remains poorly defined, and its relevance to bacterial immunity is entirely unknown. Our key conceptual
contribution to the nascent PACC1 biology field is that PACC1 may play a critical function in the highly acidic and
chloride-packed phagolysosome in myeloid cells. To explore this, we have generated PACC1-deficient (PACC1-
/-) mice, which our data suggest have defects in phagolysosomal acidification when challenged with bacteria.
Accordingly, this defect is associated with increased susceptibility to S. pneumoniae infection in the lung and E.
coli infection in the peritoneum and blood, compared to wildtype mice. Dysregulated hyperinflammation and
myeloid cell recruitment in PACC1-/- mice are unable to clear infection. In this proposal, we will test our hypothesis
that PACC1 provides protection by promoting myeloid cell responses during bacterial infection, particularly in
alveolar macrophages, by supporting phagolysosomal acidification and bacterial killing. Our innovative approach
will leverage multiple disease models (pneumonia and sepsis), novel mouse strains, and transcriptomics, to
uncover the role of PACC1. In Aim 1, we will test if global PACC1 loss in PACC1-/- mice impairs phagolysosomal
and effector functions in myeloid cells in vitro (Aim 1.1); and impair bacterial killing by myeloid cells in vitro and
by alveolar macrophages in vivo (Aim 1.2). In Aim 2, we will study the myeloid cell-specific role of PACC1 during
infection in vivo. We will infect novel myeloid cell conditional PACC1 knockout mice with S. pneumoniae to study
clinical severity and immunologic responses, and probe mechanisms using phagolysosomal proton pump
inhibitors and neutrophil-depleting antibodies (Aim 2.1). We will also test if PACC1 loss in alveolar macrophages
and neutrophils results in deleterious transcriptomic perturbations during pneumococcal pneumonia via RNA-
sequencing (Aim 2.2). Finally, we will test if novel myeloid cell conditional PACC1 overexpressing knockin mice
are resistant to pneumonia due to improved phagolysosomal bacterial clearance (Aim 2.3). Overall, our goal will
be to elucidate a beneficial role for PACC1 in myeloid cells during bacterial infection, while pursuing a rigorous
training platform for my development as an independent pulmonary immunology researcher.

Public health relevance
Project Narrative Bacterial diseases constitute a major global burden, primarily due to respiratory, peritoneal, and blood infections. In this proposal, we will test our hypothesis that a newly discovered acid-sensitive chloride channel, proton- activated chloride channel 1 (PACC1), may provide protection by promoting myeloid cell responses during bacterial infection—especially from tissue-resident alveolar macrophages—possibly by supporting phagolysosomal acidification and bacterial killing. Our innovative approach will leverage multiple bacterial pathogens (Streptococcus pneumoniae, Escherichia coli); organ systems (lung, peritoneum); novel myeloid cell conditional PACC1 knockout and PACC1 overexpression mouse strains generated by our lab; and transcriptomics, to elucidate the role of PACC1 in pneumococcal pneumonia and sepsis, all while serving as an integrated training plan for my development as an independent pulmonary immunology researcher.